NMR Research Core Facility

The NMR Research Core Facility consulted on many projects in FY2021. The following investigators utilized the facilities.

Paul Doetsch: The NMR core provided metabolomic analyses of yeast extracts.
R. Scott Williams: The NMR core provided structural analyses of proteins related to DNA damage and repair pathways.
Traci Hall: RNA structures were determined, and the binding of proteins were localized to structural features on the RNA structure.
Jason Watts: The NMR core examined nucleotide samples for evidence of G quadruplex formation.
Guohong Cui: The NMR core tested chemicals for authenticity
Gaylia Jean Harry: Metabolomic samples of brain extracts were characterized.
Suchitra Kaveri Hourigan: Fecal samples from leukemia survivors were characterized.
Anton Marinus Jetten: Metablomic samples of liver, serum, and feces were examined for differences due to genetics and diet.
Thomas Anthony Kunkel: Exonuclease domains were studied for dynamic responses.
Cynthia Vanessa Rider: Botanical extracts were characterized.
Jason Alexander Watts: Fecal samples from patients with chronic fatigue syndrome were characterized for metabolites present.